5-HT NEURONS AND MEAL REGULATION

PROJECT SUMMARY
Despite the rapidly growing rate in obesity and tremendous efforts in weight loss research, the development of
safe and effective therapeutics has progressed significantly, yet is still limited, largely due to insufficient
understanding of how the brain manages body weight and feeding. Lorcaserin, a 5-HT (serotonin) receptor
agonist, showed great promise for effectively reducing weight, but was withdrawn due to increased risk for cancer
development. 5-HT remains an excellent potential target for an anti-obesity therapeutic, but more work needs to
be completed to determine the most effective way for targeting 5-HT. Previous work in this area has shown that
GABA and dopamine inhibition of 5-HT neurons is critical for mediating food intake in mice. In fact, my preliminary
work has revealed that 2 (GABA receptor subunit) deletion in TPH2 (rate limiting enzyme for 5-HT synthesis)
neurons causes a decreased meal number and increased meal interval compared to wild-type mice, indicating
a potential dysfunction in meal initiation. Furthermore, DRD2 (a dopamine receptor) deletion reduced miniature
inhibitory post synaptic current (mIPSC) in TPH2 neurons, indicating that DRD2 plays an essential role in
mediating 5-HT neuronal response to GABA inhibitory input. Finally, I found that in hungry mice, the selective
activation of 5-HT neurons in the Dorsal Raphe Nucleus (DRN) which project to the Arcuate Nucleus (ARH) in
the Hypothalamus during food approach significantly reduces food intake compared to control mice. Taken
together, these preliminary data led me to the hypothesis that GABA inputs to 5-HTDRN neurons are regulated, in
part, by DRD2 and may contribute to the regulation of meal initiation. The focus of this proposal is to 1) determine
whether the 5-HTDRN→ARH circuit regulates meal initiation and 2) to determine whether DA influences GABA
signaling to ARH-projecting 5-HTDRN neurons for meal initiation. To achieve these goals, I will examine (1)
whether photostimulation or photoinhibition of the 5-HTDRN→ARH circuit during food approach alters meal
initiation and food intake, and (2) the dynamic activity of ARH-projecting 5-HTDRN neurons before or during food
approach, at meal initiation, eating and meal termination using fiber photometry. Further, I will generate mice
with a selective deletion of either the GABAA γ2 subunit or DA receptor DRD2 in ARH-projecting 5-HTDRN neurons
and perform metabolic and meal pattern studies, and (2) examine the electrophysiological properties (mIPSC,
resting membrane potential, action potential firing, and their responses to GABA or DRD2 agonists) of ARH-
projecting 5-HTDRN neurons in which either the GABAA γ2 subunit or DA receptor DRD2 is deleted. With support
from this fellowship, I will utilize the extensive resources at Baylor College of Medicine to expand my expertise
so that I can advance in my career and learn more novel and comprehensive approaches to studying the
mechanisms underlying meal initiation. This opportunity will provide me with the necessary tools to enhance my
training and move toward my career goal of becoming an independent research scientist at an academic
institution.

Public health relevance
PROJECT NARRATIVE Despite the rapidly growing rate of obesity, the development of safe and effective therapeutics has become progressively more promising, yet still limited, largely due to insufficient understanding of how the brain manages body weight and feeding. Serotonin remains an excellent potential target for an anti- obesity therapeutic, but there is a gap in understanding of the most effective way to utilize serotonin as a tool for weight loss. This proposal will focus on how 5-HT (serotonin) neurons are regulated by dopamine and/or GABA, and how these inputs contribute to the meal initiation.